Analysis of Centrosome Dynamics

PROJECT SUMMARY
Centrosomes, the major microtubule organizing centers in animal cells, are duplicated precisely once per cell
cycle to catalyze microtubule generation for rapid bipolar spindle assembly and ensure accurate chromosome
segregation. Centrosome amplification and fragmentation are frequently observed in cancer cells and are
thought to contribute to their chromosome instability and aneuploidy. Centrosomes are comprised of a centriolar
core that recruits pericentriolar material matrix to dock microtubule-nucleating g-tubulin-containing complexes
(γTuCs). Given the central role of centrosomes in cell division and their frequent aberration in cancer, there has
been significant interest in developing centrosome-targeting agents for cancer therapy. In this proposal, we
elucidate distinct centrosomal microtubule generation mechanisms that contribute to spindle formation and
address how the primacy of the centrosome as the dominant site for spindle microtubule generation is
maintained. The dominance of centrosomes as mitotic microtubule nucleation centers, which reinforces bipolarity
of the spindle, is ensured in part by the mitotic kinase PLK1, which independently controls expansion of the
pericentriolar matrix and matrix-anchored microtubule nucleation during mitotic entry. PLK1 executes both tasks
by phosphorylating distinct regions of the primary structural component of the pericentriolar matrix (CDK5RAP2
in humans, Cnn in Drosophila and SPD-5 in C. elegans). In Aim 1, we will pursue parallel biochemical and in
vivo approaches in the C. elegans embryo to determine how PLK-1 phosphorylation remodels the pericentriolar
matrix component SPD-5 to enable gTuC docking and activation. We will also determine how centrioles recruit
and organize the mitotic pericentriolar matrix and dictate its size, inspired by preliminary data indicating that the
mitotic pericentriolar matrix is not simply an expansion of interphase pericentriolar matrix, but is an independent
entity. In addition to phosphoregulation enforcing dominance of centrosomes as microtubule-generating sites,
the primacy of the centrosome is ensured by the ubiquitin ligase TRIM37, which functions as a “guardian of the
centrosome”. TRIM37 prevents rogue collections of centrosomal proteins from forming ectopic microtubule-
organizing centers. In Aim 2, we address how TRIM37 recognizes and suppresses ectopic centrosomal protein
assemblies, by focusing on its signature TRAF domain that is unique in the TRIM superfamily, its potential ability
to oligomerize, and its ubiquitin ligase activity. Centrosomes in human cells have at least two mechanisms for
microtubule generation that independently support spindle assembly: the well-studied pericentriolar matrix-
anchored mechanism and a pericentriolar matrix-independent centriole-anchored mechanism. In Aim 3, we
investigate the assembly and function of a specific type of ectopic microtubule-organizing center formed in
TRIM37 mutant cells that is independent of the pericentriolar matrix, concentrates core centriolar proteins, and
robustly supports spindle formation in the absence of centrosomes. This effort should shed light on poorly
understood pericentriolar matrix-independent mechanisms for spindle microtubule generation in human cells.

Public health relevance
PROJECT NARRATIVE The mitotic spindle, the football-shaped cellular machine that segregates the replicated chromosomes into the two daughter cells, is formed by microscopic cellular structures called centrosomes, which are comprised of a highly interconnected network of ~150 proteins. Centrosome duplication occurs precisely once every cell cycle to ensure that dividing cells have exactly two centrosomes, and thus two poles of the football-shaped spindle. The goal of this project is to understand how centrosome assembly reactions and the capacity for spindle pole organization are confined to the centrosome, thereby preventing the formation of aberrant multipolar spindles that have the potential to generate cells with inaccurate chromosome numbers and promote tumorigenesis.